Boston Roybal Center for Active Lifestyle Interventions

Project Summary:
The Boston Roybal Center for Active Lifestyle Interventions (RALI Boston) Management and Administrative
Core A (MAC) provides scientific direction and organizational oversight for the entire project. We will address
one of the most pressing and challenging problems of our time, namely, how to motivate adults to adopt and
maintain an active lifestyle. The major goal of the MAC Core A is to oversee and coordinate all components
and activities of RALI Boston across the five participating universities: Brandeis University, Northeastern
University, Boston College, Boston University, and Harvard Medical School/Hebrew Senior Life. The specific
aims of the MAC are: 1) to coordinate and oversee all components of the RALI Boston Center; 2) to reach out
to and collaborate with community organizations that serve diverse older adult populations to guide the design
and conduct of pilot studies; 3) to engage in activities that create a stimulating environment and foster
cohesiveness and productivity among RALI Boston investigators across institutions and promotes evidence-
based translational research; and 4) to solicit feedback from external advisors and conduct ongoing
evaluations of the Center to ensure we meet all of our aims. The MAC will enable RALI Boston to continue its
growth as a leader in evidence-based clinical trials using the NIH Stage Model for behavioral interventions and
translational research. The MAC co-leaders (Drs. Margie Lachman and Carmen Sceppa) will share
responsibility for overseeing all operations and activities of the Center. They will work in conjunction with the
Pilot Core B to solicit, review, implement, and evaluate pilot projects. The MAC will be responsible for
maintaining the scientific integrity of our research and will engage in problem solving, communication,
meetings, seminars, and evaluation of progress. The MAC responsibilities will continue to be implemented
through an Executive Committee represented by the five RALI Boston collaborating institutions, as well as ad
hoc subcommittees and working groups, External Scientific and Community Advisory Committees, and
affiliated faculty, including pilot investigators and other faculty from the five institutions. The Executive
Committee consists of the MAC Co-leaders (Lachman, Sceppa), Pilot Core Leaders (Drs. Lachman, Lewis
Lipsitz and Theresa Ellis), Dr. James Lubben, and Dr. Art Kramer – all leaders in their respective fields and
senior representatives of their institutions. Most of these members have already established strong working
relationships during our current funding period, as evidenced by their weekly 7 AM meetings, collaborative
research activities, co-authored publications, and successful co-mentoring of junior faculty. They bring
extensive multidisciplinary expertise and resources in aging, behavioral science, psychology, sociology,
exercise physiology, neuroscience, and clinical trials, and share the common goal of developing and testing
interventions to increase physical activity to increase the health and well-being of vulnerable populations.